Aging and the nuclear lamina in mitotic stem cells

PROJECT SUMMARY
Tissue homeostasis depends upon the regulated production of differentiated cells to replace
those that are damaged or defective. Homeostasis declines with age, largely because of
decreases in stem cell number and/or function. To intervene in the aging process, it is critical to
understand mechanisms involved in stem cell homeostasis. We discovered that paradigmatic
Drosophila female germline stem cells (fGSCs) use a non-canonical mode of mitosis, wherein
the nuclear envelope and nuclear lamina remain throughout mitosis. In this mode, mitotic
spindles are nucleated from centrosomes embedded in the retained nuclear lamina. This mode
of mitosis has gone unrecognized, due to the rarity of stem cell divisions and the globally
accepted assumption that metazoan mitoses involve nuclear lamina dispersal. As such, how the
mitotic nuclear lamina impacts asymmetric stem cell divisions and stem cell maintenance is
unknown. The long-term goal of these studies is to define contributions of the mitotic nuclear
lamina to fGSC homeostasis during aging. We capitalize on this natural in vivo stem cell
population that demonstrates rapid, age-dependent declines in stem cell functions to address
two aims. Aim 1 will define how biological aging affects the mitotic nuclear lamina. Aim 2 will
define the role of the nuclear lamina checkpoint kinases in physiological aging. Experiments in
this proposal will establish contributions of the newly identified mitotic nuclear lamina to stem
cell maintenance. These studies have the potential to provide insights into lamin associated
diseases such as progeria and provide insights to advance therapeutics that delay or
eliminate stem cell loss during natural aging.

Public health relevance
PROJECT NARRATIVE Prominent changes in nuclear morphology occur during physiological aging and in age- enhanced diseases, such as laminopathies. We discovered that paradigmatic Drosophila stem cells retain the nuclear envelope and nuclear lamina remain throughout mitosis, sensitizing these stem cells to the function of nuclear lamina proteins. Understanding the role of this non-canonical mode of mitosis during aging has the potential to provide new avenues of inventions during aging and will provide insights into human laminopathic premature aging diseases, such as progeria.